NHLBI ENTERPRISE BUSINESS INTELLIGENCE (TASK ORDER ETA)

Provides comprehensive business intelligence reporting and analytics that allow users to easily and quickly filter, pivot, and process data from multiple data sources, extract business-critical insights from datasets, and distribute the information accurately and responsibly to organizational stakeholders in readily useable formats.